Striatal Trans-Synaptic Signaling Mechanism in Parkinsonism

Summary:
In the United States alone each year an estimated 60,000 individuals are diagnosed with Parkinson's disease (PD)
with an economic cost of over fifty billion dollars each year. The individuals with Parkinson's disease show severe
hypokinetic motor symptoms as well as anxiety, depression and cognitive decline. There are currently no treatments to
prevent the progression of PD. Thus, identifying novel therapeutic targets is essential to address this clinical burden. The
primary disease pathology involves degeneration of dopamine-producing neurons in the substantia nigra which triggers
maladaptive changes in the striatum that underlie some of the motor and possibly non-motor symptoms in PD. Recent
studies have identified an important contribution of the thalamostriatal system to behavioral deficits in PD models.
Changes in function of synapses at parafascicular thalamus (Pf) inputs to medium spiny neurons (MSNs) has been
observed in mice with 6-OHDA lesion. Importantly, chemogenetic or optogenetic inhibition of Pf neurons or their
terminals in the striatum alleviates motor dysfunction in PD models. Therefore, identification of mechanisms underlying
this defect has potential to improve motor and non-motor function in PD. Based on our recent studies and preliminary data
we hypothesize that glutamate delta 1 receptor (GluD1)-cerebellin 1 (Cbln1) complex and associated synaptic organizers
contribute to PD-related changes in thalamostriatal function and therefore can be targeted to mitigate behavioral deficits.
Specific Aim1 will examine the effect of dopamine-depletion on GluD1-Cbln1 and associated synaptic organizer
expression in an acute neurotoxin as well as a progressive genetic mouse models of PD. Changes in ultrastructure of
striatal synapses in PD models will be evaluated using 3D-electron microscopy. Specific Aim 2 will determine the
relationship between changes in synaptic organizer levels, synaptic properties and motor and non-motor behaviors.
Specific Aim 3 will determine the effect of genetic and pharmacological restoration of normal GluD1-Cbln1 trans-
synaptic signaling in rescuing synaptic changes and mitigating behavioral deficits in PD models. To accomplish these
aims we will utilize a combination of confocal and electron microscopy (immuno and 3D), brain slice electrophysiology,
behavior, optogenetics and genetic approaches to determine the contribution of synaptic organizers in striatal
neuroplasticity and behaviors in PD. This project is significant because it would identify therapeutically targetable
strategy to alleviate PD motor and non-motor deficits and/or modify disease progression. Scientific rigor of research
design is established by the use of multiple methods and approaches, replication of experiments in independent
laboratories, use of validated models and reagents, consideration of blinding, biological variables and sex in addition to
other aspects of experimental design.

Public health relevance
Narrative: Parkinson's disease is a severe neurodegenerative disease. Current treatments are symptomatic and do not prevent disease progression. Thus, there is a need to identify new therapeutic targets. Neuroplasticity in the striatum has been found to underlie motor impairments in Parkinson's disease. However, the role of synaptic organizes in these neuroplastic changes and contribution to motor and non-motor dysfunction is not known. We propose to understand the role of a type of glutamate receptor which serves as a striatal synaptic organizer in neuroplasticity and behavioral impairment associated with Parkinson's disease.